Multi-Omics and NETwork Analysis Summer Workshop (MONET)

For more than a decade genome-wide association studies (GWAS) have provided insight into the genetic
basis of a variety of complex diseases, physiological traits, and molecular phenotypes. Biomedical researchers
are increasingly linking genome wide data (e.g., DNA variants, DNA methylation, chromatin accessibility) with
other high-throughput molecular data (e.g., transcripts, proteins, metabolites). These additional omics
technologies have been useful for extending the biological relevance of GWAS findings by providing functional
interpretation of GWAS signals, biomarker identification, disease subtyping, and understanding of molecular
processes that underlie disease etiology in relevant tissues. Despite the promise offered by multi-omics data,
analysis is often challenging due to multiple large and high-dimensional data sets; heterogeneity across
technologies, coverage, range, and signal quality; decisions about how and when to integrate data; and the lack
of data from diverse subjects. The multi-omics field is quickly evolving, and we and others have developed
methodology regarding multi-omics analyses. In particular, network science and graph analytics has been an
intuitive framework for identifying interactions across omics modalities. In response to PAR-22-095 (“National
Human Genome Research Institute (NHGRI) Short Courses for Genomics-Related Research Education”), we
have developed the Multi-Omics and NETwork analysis workshop (MONET) to provide an interactive experience
to learn about multi-omics analysis and the application of network methods. The MONET training would
complement the mission of NHGRI as genetic analyses are frequently being integrated with other omics profiles
and it is increasingly important to have a trained workforce that has familiarity with multi-omics tools. For
MONET, we propose a 7-day immersive experience for ~25 researchers each summer 2024-2028. MONET will
consist of ~50 hours of lectures, discussion sessions, computational labs, and tours. Each day will include
didactic portions providing overviews of the technologies and methods. The rest of the time will primarily be
devoted to hands-on sessions where participants will implement methods using provided sample code and data
sets. So that participants also understand how data are generated, we will organize tours of our technology
cores, in addition to an outing to an industry partner. We will also include discussion sessions on cross-cutting
topics for multi-omics research including omics data preparation, harmonization, and computing, in addition to
omics data sharing, privacy and policy issues. Finally, multi-omics research requires a team science approach
which will be developed through group exercises. Participants will be post-baccalaureate researchers (e.g.,
MS/PhD students, research staff, post-doctoral fellows, clinical fellows, junior and senior research investigators)
who have interest in analyzing multi-omics data and sufficient programming knowledge to follow data analysis
procedures. Instructors will be drawn from experts with experience in genetics, bioinformatics and data science
at the University of Colorado Anschutz Medical Campus, affiliated institutions, and external guest lecturers.

Public health relevance
Biomedical researchers are increasingly linking genome wide data with other omics data to understand the biological relevance and molecular processes underlying genome-wide association study signals. The Multi- Omics and NETwork analysis workshop (MONET) will provide a 7-day immersive experience for ~25 researchers each summer 2024-2028 to learn about multi-omics analysis and the application of network methods through ~50 hours of lectures, discussion sessions, computational labs, tours and team exercises.